Science/Technical Core

SCIENTIFIC/TECHINCAL CORE: PROJECT SUMMARY
The PSTC’s Science Core provides advanced research tools and expert technical assistance to support the
innovative and interdisciplinary research agendas of the Center’s population scientists. This Core provides
PSTC affiliates with outstanding research programming services, support for survey data collection,
specialized assistance in spatial and GIS programming, and state-of-the-art computing and IT infrastructure.
Researchers also receive assistance in compliance with confidentiality requirements related to population data
collection, management, and analysis; and secure data room access and maintenance. These various
services provide opportunities to develop affiliates’ ability to use and disseminate innovative research tools
and approaches to population science The PSTC seeks to produce excellent population science, and the
Science Core provides the concrete technical support to achieve this aim.